Non-Preferred Contraceptive Method Use in Low-Resourced Settings: Exploring Inappropriate Medical Contraindications and Person-Centered Care

PROJECT SUMMARY/ ABSTRACT
Family planning prevents unwanted pregnancy and reduces maternal and child mortality in low-resourced
settings; however, women in these settings encounter unnecessary medical barriers to contraceptive care.
Inappropriate medical contraindications (IMCs) occur when providers deny eligible women their preferred
contraceptive method without an evidence-based medical rationale. This medical barrier to family planning use
is difficult to identify using traditional survey methods and has been understudied for the last 20 years. The
applicant’s previous research suggests non-preferred method use is one indicator of IMCs, as 55% of non-
preferred method users reported a ‘medical reason’ for nonuse. Further, qualitative data on medical reasons
for non-use revealed IMC application by providers. Non-preferred method use is undesirable, as it can lead to
dissatisfaction, discontinuation, and unplanned pregnancies. Identifying interventions that effectively reduce
non-preferred method use and IMCs is an important contribution to global public health. The applicant’s long-
term objective is to identify effective and scalable interventions for reducing medical barriers to contraceptive
care for women living in low-resource settings. The proposed project will 1) estimate the impact of two social
accountability interventions on non-preferred method use at the population level; 2) determine the frequency
and elucidate the nature of non-preferred method use due to IMCs using innovative mystery client data
collected among 137 public-sector Kenyan facilities, and 3) use qualitative methods to investigate provider
perspectives on non-preferred method use and IMCs to explore key factors. The applicant hypothesizes that
social accountability interventions, in which community oversight motivates providers to improve their
performance, could increase patient-centeredness of care and therefore reduce non-preferred method use. To
test this hypothesis, Aim 1 will use difference-in-difference methods to analyze pre- and post-intervention data
from a randomized controlled experiment assessing two social accountability interventions in Kisumu, Kenya.
Aim 2 will use mixed methods to analyze mystery client data collected from all public facilities in Kisumu,
Kenya. Aim 3 proposes in-depth interviews with family planning providers in Kisumu, where the applicant will
build a new skill – standardized vignettes – to understand and contextualize provider decision-making around
IMCs. These data collection methods will overcome major methodological challenges that have prevented
research into IMCs in the past 20 years. Results will contribute important new information for improving
contraceptive care in low-resource settings. Additionally, the proposed rigorous training and research plans will
support the applicant in developing specialized subject knowledge, building mixed methods expertise, and
advancing in their development as an independent researcher.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health as it investigates prevalence of, root causes of, and an intervention to address an under-studied medical barrier to family planning use: when providers deny a preferred method of family planning with an illegitimate or inappropriate medical rationale. Preventing the application of inappropriate medical contraindications would improve person-centeredness of family planning services and has the potential to reduce contraceptive discontinuation due to dissatisfaction with a non- preferred family planning method. This project leverages innovative and rigorous data from an NIH-funded parent study - including mystery client observations and a cluster randomized design - and implements a mixed-methods approach to address a challenging, impactful, and understudied barrier to contraceptive access in the Global South.